TASK ORDER 01. RECEPTOR BINDING AND PREDICTIVE TOXICOLOGY. EUROFINS PANLABS INC. N01DA-23-8937. POP SEPTEMBER 26, 2023 TO SEPTEMBER 25, 2024.

Assessment of Potential Substance Abuse Treatment Medications in Nonhuman Primate Models (McLean Hospital) (OPTION)